2021 RNA Editing Gordon Research Conference & Seminar

Project Summary/Abstract: The GRC on RNA editing is the premier international meeting dedicated to nucleic acid modifications. The 2021 meeting is subtitled: “RNA/DNA editing and epitranscriptomics across biological systems”. Modifications to the common nucleosides found in DNA and RNA have been known for many years. However, recent advances in analytical techniques for their detection, along with a deeper understanding of the broad impact these modifications have on fundamental biological processes, including human disease, have caused a renaissance in their study. Indeed, we now know that nucleic acid modifications are common in various naturally occurring nucleic acids and influence gene expression, protein synthesis, cognition, innate and adaptive immunity, autoimmune disease and cancer. Furthermore, several research labs have repurposed enzymes that naturally edit RNA or modify DNA bases for targeted genome editing. This meeting will bring together a diverse group of scientists with varying expertise with the common goal of sharing ideas and approaches that can advance our understanding of the many facets of nucleic acid modifications. This conference has three specific aims. First, we will support the development of the next generation of scientific leaders. Key to achieving this aim is supporting the accompanying Gordon Research Seminar (GRS). In the two days preceding the GRC, a GRS will take place that is focused on the exchange of research data and ideas among graduate students and post- docs in the editing and modification field. Our second specific aim is to facilitate knowledge exchange on DNA and RNA editing and modification. During the five-day GRC, there is approximately four hours in each afternoon for networking, there are four poster sessions, and 49 speakers covering all aspects of DNA and RNA editing research to foster interdisciplinary and collaborative interactions. Our third aim is to connect academic researchers to stakeholders in industry. Representatives of gene editing companies and biomedical science companies with an editing/modification focus will participate in the 2021 conference. This interaction will facilitate collaboration with companies or other labs that can take basic health related research to the next level of developing treatments for genetic diseases.

Public health relevance
Project Narrative: The Gordon Research Conference on RNA editing is the premier international meeting dedicated to nucleic acid modifications which are common in the various naturally occurring nucleic acids and influence gene expression, protein synthesis, cognition, innate and adaptive immunity, autoimmune disease and cancer. Furthermore, several research labs have repurposed enzymes that naturally edit RNA or DNA for targeted genome editing. This meeting will bring together a diverse group of scientists with varying expertise with the common goal of sharing ideas and approaches that can advance our understanding of the many facets of nucleic acid modifications and to achieve the goal of taking basic health related research to the next level of developing treatments for human disease.